TRANSCRANIAL MAGNETIC STIMULATION FOR THE TREATMENT OF METHAMPHETAMINE/COCAINE USE DISORDER (CTN-0108). 9/21/2020-7/17/2023. N01DA-19-2250. TASK ORDER

Transcranial Magnetic Stimulation for the Treatment of Methamphetamine/Cocaine Use Disorder (CTN-0108).